Heat Therapy for the treatment of post-acute COVID-19 syndrome

Post-acute sequelae of SARS-CoV-2 infection (PASC) affects 5 out of 10 patients hospitalized for the
coronavirus disease 2019 (COVID-19) and ~11% of all adults infected by SARS-CoV-2, which makes this
condition a growing public health concern. It is associated with important disabilities, cognitive dysfunction, and
increased risks for cardiovascular and metabolic diseases. Although exercise-based intervention is a promising
rehabilitation strategy, participation rates are commonly low in clinical population. In addition, post-exertional
malaise, a common symptom with PASC, is a major safety concern in these patients, which may prevent a
significant proportion of these individuals to receive adequate rehabilitation. In this context, there is a critical
need to develop well-tolerated and effective strategies at home that ameliorates health and functional capacity
in individuals with PASC. One promising approach that offers numerous health benefits is whole-body heat
therapy. Whether this intervention is effective when confined to the lower body and well tolerated at home in
people with PASC is, however, unknown. The overall objective of this project is to determine the safety,
tolerability, and efficacy of home-based lower body heat therapy in late middle-age and older adults with
PASC. We will test the central hypothesis that home-based lower body heat therapy is safe, well adhered, and
can improve functional capacity and several surrogate markers for metabolic and vascular health in late-middle
age and older adults with PASC. Specific Aim 1 will test the hypothesis that lower body heat therapy at home is
safe, well adhered, and improve both cognitive and physical function in middle-age and older adults with
PASC. Selected participants will be randomly allocated to perform 8 weeks of home-based lower body heat
therapy (HT, skin temperature 38-40˚C, 40-55 min, 5 per week at home), a thermoneutral condition (CT, skin
temperature 33˚C, same duration and frequency), or a walking intervention using wearable technology (WT,
1,500-3,000 additional steps from baseline, 3-5 days per week). We will compare the 6 min walking distance,
the short physical performance battery test score, gait speed, cognitive function, incidence of adverse events,
and participant’s adherence to intervention between groups. Specific Aim 2 will test the hypothesis that heat
therapy will attenuate inflammation, which will then decrease arterial stiffness, and improve both vascular
endothelial function and muscle intracellular O2 availability in individuals with PASC. We will use in vitro assays
on blood samples and Doppler ultrasound techniques to assess changes in inflammation, redox status, pulse-
wave velocity, and flow-mediated dilation. Muscle intracellular O2 availability will be measured by magnetic
resonance spectroscopy in vivo. Specific Aim 3 will test the hypothesis that lower body heat therapy will
improve glucose control as a result of enhanced mitochondrial function. All these effects will not be statistically
inferior to the WT group. The proposed research is highly significant as it is easily translatable and is expected
to guide future rehabilitation strategies to mitigate long-term disabilities in patients with PASC.

Public health relevance
Post-acute sequelae of SARS-CoV-2 infection (PASC) is becoming a major risk factor for chronic diseases, with older adults and those with underlying health conditions at risk of developing persistent mobility limitations and disabilities. Although exercise intervention is a common strategy to restore functional capacity, it may not be feasible or enticing to many people with PASC. This clinical trial seeks to establish the tolerability and efficacy of at home lower-body heat therapy for improving functional capacity along with metabolic and vascular health in late-middle aged and older adults with PASC, also known as “long COVID”.